Inflammatory Biomarkers in Pediatric Obesity and Diabetes: Research and Mentoring

DESCRIPTION (provided by applicant): Pietro Galassetti, MD PhD, is an Associate Professor in the Departments of Pediatric and Pharmacology of the University of California, Irvine, where he also serves as Director of the Metabolism and Bionutrition Core at the Institute for Clinical and Translational Science (ICTS, formerly GCRC). He has been involved in Patient Oriented Research for the last 20 years, and currently is PI on 2 extramural grants (including an NIH RO1), focused on projects with the common theme of defining the biochemical mechanisms underlying the early development of complications in dysmetabolic states, such as obesity, metabolic syndrome, type 1 (T1DM) and type 2 diabetes (T2DM). His current main specific research topics are: a) The development of a non-invasive technique for the measurement of plasma glucose, insulin and lipids through integrated analysis of exhaled volatile organic compounds; b) The definition of inflammatory and oxidative stress mechanisms during exercise in children with obesity and metabolic syndrome. These projects are fully patient-oriented and translational in nature. Maintaining and improving adequate research funding for the evolution of these projects will be challenging in coming years. With this application, support for 50% of Dr. Galassetti's professional effort is requested, of which half, or 25% of his total time, will be devoted to completing novel, exploratory experiments in the 2 research areas outlined above, aimed at facilitating the acquisition of additional research funding. Dr. Galassetti has published extensively on translational research topics in high-impact journals (35 published peer reviewed papers in the last 5 years only, out of a total of 78); he acts as reviewer to over twenty scientific journals, several grant funding agencies (NIH, JDRF, and other national and international foundations). A large share of Dr. Galassetti's time is taken up by mentoring activities, These include: a) direct mentoring of UCI residents, fellows, medical and graduate students who participate in Dr. Galassetti's research projects; b) mentoring of junior faculty who are trying to develop independent research lines; c) mentoring of junior investigators involved in clinical-translational projects with other PIs, requesting Dr. Galassetti's expertise; d) mentoring through structured UCI mechanisms, such as the Bio 199 Clinical Research Course, Internships for the UCI Clinical Trial Courses, the UCI Mentored Medical Student Clinical Research Program, the Neonatology Fellows Scholarship Oversight Committee, etc. Many of his trainees co-authored abstracts and papers based on recent study results, and several have won regional and national research awards while under his mentorship. The remaining 25% of the requested salary support will therefore be devoted to the continuation and expansion of these mentoring activities. In summary, Dr. Galassetti is fully committed to a career in Patient Oriented Research. This award will allow to considerably reduce his current onerous amount of administrative and service duties, and proportionally increase protected time dedicated to mentoring and research activities in translational science.

Public health relevance
PUBLIC HEALTH RELEVANCE: Pietro Galassetti, MD PhD, is a researcher at the University of California, Irvine, and has been involved in Patient Oriented Research for 20 years. He has 2 funded research projects, with the common theme to define the early development of complications of obesity and diabetes: a) The development of a novel technique to measure glucose, insulin and fat from human breath (i.e. not requiring a blood sample); b) The study of the damage from inflammation and free radicals during exercise in obese children. Both projects are clear examples of patient-oriented research. With this application, 50% salary support is requested for Dr. Galassetti's; of which 25% will be devoted to novel, exploratory experiments that will expand current projects and facilitate acquisition of additional research funding. Dr. Galassetti has published extensively in high-level scientific journals (35 papers in the last 5 years, out of a total of 78). A large share of Dr. Galassetti's time is taken up by mentoring activities, for UCI clinical residents and fellows, post-doctoral fellows, medical and graduate students. The remaining 25% of the requested salary support will be devoted to the continuation and expansion of these mentoring activities. In summary, Dr. Galassetti is fully committed to a career in Patient Oriented Research, and this award will result in reduced administrative duties and more protected time, increasing his current levels of mentoring and research activities. Pietro Galassetti, MD PhD, is a researcher at the University of California, Irvine, and has been involved in Patient Oriented Research for 20 years. He has 2 funded research projects, with the common theme to define the early development of complications of obesity and diabetes: a) The development of a novel technique to measure glucose, insulin and fat from human breath (i.e. not requiring a blood sample); b) The study of the damage from inflammation and free radicals during exercise in obese children. Both projects are clear examples of patient-oriented research. With this application, 50% salary support is requested for Dr. Galassetti's; of which 25% will be devoted to novel, exploratory experiments that will expand current projects and facilitate acquisition of additional research funding. Dr. Galassetti has published extensively in high-level scientific journals (35 papers in the last 5 years, out of a total of 78). A large share of Dr. Galassetti's time is taken up by mentoring activities, for UCI clinical residents and fellows, post-doctoral fellows, medical and graduate students. The remaining 25% of the requested salary support will be devoted to the continuation and expansion of these mentoring activities. In summary, Dr. Galassetti is fully committed to a career in Patient Oriented Research, and this award will result in reduced administrative duties and more protected time, increasing his current levels of mentoring and research activities. __SpecificAimsTextDelimiter__ OVERVIEW Two main research projects are currently ongoing in my laboratory, with the common theme of the definition of biochemical mechanisms underlying the early development of complications in dysmetabolic states, such as obesity, metabolic syndrome, Type 1 (T1DM) and Type 2 diabetes (T2DM). SPECIFIC AIMS WILL BE THEREFORE LISTED BY PROJECT, AND DISTINGUISHED BETWEEN FUNDED AND PROPOSED PROJECT I - Non-invasive measurement of endogenous metabolism variables through exhaled breath analysis in healthy, obese and diabetic patients. Currently funded by American Diabetes Association grant # 7-08-CR-22 (in its second of three years) Currently Funded Specific Aims I-1 To predict plasma glucose, insulin and free fatty acids (FFAs) via integrated analysis of exhaled gas profiles, in healthy, obese and diabetic individuals I-1a During rapid induction and correction of hyperglycemia (eu- and hyper-glycemia with/without hyperinsulinemia; hyperinsulinemia with/without FFA suppression). I-1b During physiological post-prandial hyperglycemia/hyperlipidemia (following single of fractioned ingestion of different combinations of carbohydrate, lipids and placebo meals). Proposed New Specific Aims I-2 Development of a breath-based technique for the early detection of hypoglycemia in subjects with Type1 diabetes I-3 Development of a breath-based insulin screening test through paired blood and exhaled gas samples in a middle school population PROJECT II - Oxidative stress mechanisms during exercise in children with obesity and metabolic syndrome Funded by NICHD P01HD048721 (Dr. Galassetti project PI), in year 4 of 5. Currently funded Specific Aims II-1 To examine for the first time in children and adolescents the oxidative stress response that occurs with brief bouts of exercise, and the extent to which these responses are altered by maturational status, gender, and levels of physical fitness. II-2 To gauge the effect of pediatric obesity/metabolic syndrome on the regulation of oxidative stress under basal conditions and during exercise. Proposed New Specific Aims II-3 To determine the effect of an exercise training program on altered oxidative stress and inflammatory markers in obese children II-4 To determine the role of neutrophil-derived oxidative and inflammatory activity in the early pathogenesis of obesity and diabetes cardiovascular complications The proposed new specific aims will constitute the research component of this application, to which Dr. Galassetti will devote 25% of his professional effort (half of the salary support requested with this application). If funded, this award will allow Dr. Galassetti, by relinquishing service and administrative duties, to increase his % professional effort dedicated to Patient Oriented Research activities to ~ 70%.